Metabolite driven mechanisms by which gut microbes impact checkpoint inhibitor success in non-small cell lung cancer patients

ABSTRACT
Immune checkpoint inhibitors (ICIs) have revolutionized cancer treatment but clinical responses remain limited
due to primary and/or acquired ICI resistance. Preliminary studies suggest the gut microbiome is an independent,
novel modulator of systemic and intra-tumoral responses to ICIs. Published studies, primarily in melanoma and
non-small cell lung cancer (NSCLC), reported a diverse gut microbiome and a few bacterial species associated
with tumor responses to ICIs. However, existing studies are limited by an oversimplified classification of
responder status and lack of longitudinal analysis. Moreover, specific bacteria or bacterial communities putatively
helpful or harmful to ICI responses have largely been inconsistent across study populations and tumor types with
only limited correlations with immune or mutational biomarkers. To address these inconsistencies, we reanalyzed
raw 16S rRNA amplicon and whole genome sequencing (WGS) fecal data from five published studies (n=303,
pre-treatment stools only) using a high dimensional computational approach and found that our predictive index
underperformed in NSCLC, the leading cause of cancer death, compared to melanoma. Thus, to further refine
this index and identify mechanisms of action for the microbiome in NSCLC ICI therapy, herein, we propose
detailed metabolite (plasma, fecal) and metagenomic (fecal, WGS) longitudinal studies of our NSCLC cohort
(n=108). We will focus our studies on patients with a durable response to ICIs, comparing them to those with
primary resistance (disease progression within 6 months) or acquired resistance (disease progression after an
initial response >6 months). Microbiota metabolite production, with the capacity to impact local and systemic
immune responses, is proposed as a ‘common pathway’ mechanism promoting anti-tumor responses. For
example, both recent literature and our preliminary data in transplantable tumor murine models suggest inosine
and short chain fatty acids (SCFA) are microbial modifiers of the tumor microenvironment. Further, a preliminary
study found SCFAs enriched in fecal sample from NSCLC patients with durable response to ICIs (n=11). We
hypothesize that specific bacterial species and/or communities promote production of SCFAs and/or inosine in
the gut and plasma of NSCLC patients who exhibit durable responses to ICI therapy whereas these are absent
in patients who exhibit primary and/or ultimately develop acquired resistance. To test our hypothesis, we propose
to identify fecal and/or plasma metabolites (SA1) and/or microbial taxa (SA2) that correlate with durable response
or ICI resistance in NSCLC patients. We will further test our hypothesis by defining the intra-tumoral immune cell
response to our patient cohorts in syngeneic murine tumor models using single cell RNAseq and paired T cell
receptor sequencing to define T cell repertoires (SA3). Our multidimensional approach, with both cross-sectional
and longitudinal translational analysis, will help define key metabolites and microbes that impact ICI resistance
in NSCLC. These studies will be foundational to my transition to independence as a physician-scientist and will
set the stage for consideration of interventional studies in NSCLC patients.

Public health relevance
PROJECT NARRATIVE Despite significant improvement in treatment using immune checkpoint inhibitors, non-small cell lung cancer remains the leading cause of cancer death, representing 22% of all cancer deaths. The gut microbiome has been identified as an independent, novel modulator of systemic anti-tumor responses to immunotherapy, but data remain limited by inconsistencies, lack of longitudinal analysis, and lack of functional characterization. The current proposal seeks to identify key metabolites and microbes or microbial communities that mechanistically impact systemic and intra-tumoral immune responses that either enhance or inhibit responses to immune checkpoint inhibitor therapy.